Combining soluble and bound factors in microstructured hydrogels to promote chronic wound angiogenesis and healing

PROJECT SUMMARY
Soluble and bound factors play a pivotal role in cell signaling, adhesion, and function to promote
wound angiogenesis and healing. Depending on the content of how these ligands are presented,
they will elicit differential signaling effects. While soluble pro-angiogenic factors initiate angiogenic
responses, bound ligands modulate the duration, intensity, and specificity of these effects.
Together, they coordinate vascular formation and maturation, ensuring efficient wound healing
while avoiding abnormal blood vessel growth and tissue fibrosis. However, developing an
integrated bioengineering system that recapitulates the complex physiological microenvironment
of wound healing with intricate balance and dynamic interactions between soluble and bound
factors, remains challenging. This proposal seeks to establish an integrated bioengineering
framework, harnessing the potential of advanced biomaterials design, innovative chemical
processes, and state-of-art fabrication techniques to present the combination of both soluble and
bound factors to better understand how these synergized dynamic physiochemical properties
govern cell signaling and modulate cell function, with a focus on chronic wound angiogenesis and
healing. To achieve this goal, we aim to apply chemical routes to delineate negative charge
attributes in synthetic heparin-mimetic hydrogels, and subsequently employ liquid-liquid phase
separation techniques to introduce microspheres into these pro-angiogenic materials, culminating
an in vitro microfluidic wound-on-a-chip model and diabetic mouse model to investigate the
cooperative effects of soluble and bound factors in cell signaling. The working hypothesis points
that combining the pro-angiogenic growth factor signaling (soluble gradient) and integrin-
mediated mechanotransduction (bound factors) in phase separated 3D synthetic matrices -
characterized with tunable charge densities and increased microstructures - will enhance cell-cell
and cell-ECM interactions that promote cell migration, infiltration, connection, ECM deposition,
and vascular network formation to induce wound angiogenesis and healing. The integration of
tunable biomaterials with a novel in vitro 3D wound injury and closure model builds a bottom-up
biomimetic system to explore the synergistic effects between soluble biochemical signals and
bound biophysical cues with the minimum components required for enhanced wound
angiogenesis and healing. This comprehensive in vitro platform of a 3D multicellular culturing
system will identify the key matrix properties for wound healing and such insights are paramount
in leading the therapeutic advancements for wound angiogenesis and chronic healing.

Public health relevance
NARRATIVE Both soluble and bound ligands play pivotal roles in regulating cell behavior and function, particularly in tissue vascularization and chronic wound healing. This proposal aims to pioneer innovative methods to fabricate multi-structured, heterogenous angiogenic hydrogels with variable ligand binding affinities as a platform to better understand how combined structural and biochemical cues orchestrate cell signaling, and to harness these insights for enhanced vasculature. Outcomes from the proposed research will elucidate differential signaling impacts and mechanisms for binding growth factors and adhesive ligands covalently and noncovalently, offering accelerated vascularization strategies for therapeutic wound healing.